The role of Esx-3 in mediating drug resistance

Tuberculosis is a major cause of human suffering worldwide, with 1.8 million deaths and 10.4
million new cases in 2015. Although effective drug regimens for the treatment of TB exist, they
are lengthy and involve multiple antibiotics to achieve sterilization and prevent relapse. The
current treatment for TB is complex and lengthy requiring a minimum of six months with four drugs
for the simplest of cases. It is not clear why drug therapy is so prolonged, although several
theories relating to the physiological state of the bacteria have been proposed; these include the
existence of drug-tolerant populations during infection, the presence of non-replicating (or slowly-
replicating bacilli) and the lack of drug penetration to the sites of infection.
Much recent effort has been expended in phenotypic screening to identify new molecular series
for drug discovery and development; alongside which a chemical genomics approach has been
taken to find novel drug targets using hit compounds identified in these screens. We are interested
both in developing novel drugs and in understanding how such drugs work. We have identified a
common mechanism of resistance to several, chemically-unrelated series in M. tuberculosis
which involves mutation in a type VII secretion system (T7SS).
We have identified compounds with interesting biological activities and which appear to work via
similar mechanisms, or at least resistance is engendered by the same mechanism. Our proposal
aims to determine the mode of action of these compounds. We propose that mode of action is via
disruption of metal ion homeostasis with additional downstream effects, which would be a novel
mechanism for future drug discovery efforts.
We have identified mutations in several components of the Esx-3 T7SS (EccA3, EccB3, EccC3
and EccD3) which confer resistance to three compound series. It is unlikely that the Esx-3 system
is the cellular target for these compounds, since mutations were found in four different genes,
including one cytosolic protein that would not form part of the complex. Therefore it seems likely
that resistance arises from a mechanism distinct from loss of compound-target binding.
We propose to take a number of approaches combining microbiology, molecular biology and
biochemistry to (i) determine the mode of action of compound series (ii) determine how the Esx-
3 T7SS can mediate compound resistance, and (iii) identify and characterize the targets of each
series.

Public health relevance
Narrative Mycobacterium tuberculosis, which causes tuberculosis, is a global pathogen of great importance, causing millions of infections and deaths every year. We are interested in how potential new drugs work and in how the bacteria become resistant to these drugs. We have discovered a secretion system that plays a role in resistance to particular compound classes. We aim to determine how the compounds kill bacteria, and how this system causes resistance.